Microbial sphingolipids and suppression of host inflammation in periodontal disease

PROJECT SUMMARY
Eukaryotic SLs are the basic building blocks of cell membranes and serve as key signaling molecules.
Bacterial synthesis of SLs is poorly understood, and almost entirely restricted to the phylum Bacteroidetes.
These microbes are generally considered symbionts of mammalian hosts. Although microbe-elicited chronic
dysregulated inflammation is central feature of soft and hard tissue destruction and periodontal disease
pathogenesis, this inflammation is, paradoxically, insufficient to clear the source of infection. Thus, subversion
of host immunity is central to the chronic nature of this disease. Research has shown that Porphyromonas
gingivalis, a member of the Bacteroidetes is uniquely capable of targeted and dynamic immune suppression,
yet little is known of the underlying mechanisms. Remarkably, our studies have illuminated the importance of
P. gingivalis SL in regulating the elicited host immune response to this organism and we have shown that
these SLs are transferred from this organism and incorporated into host cells – putatively understood as an
interkingdom communication system. The overarching hypothesis of the research we propose is that synthesis
of SLs affords P. gingivalis and possibly other oral Bacteroidetes a mechanism of immune regulation.
Specifically, our published and preliminary studies have determined that P. gingivalis secretes SL-containing
outer membrane vesicles (OMVs) that elicit only mild inflammation compared to OMVs from a P. gingivalis
mutant incapable of synthesizing SLs, and that the phosphoglycerol-dihydrocerimides (a subset of SLs)
containing OMVs are particularly adept at immune suppression. We are proposing that SL-OMVs are an
exquisite delivery system that forms the basis of a mechanism of P. gingivalis-host communication to control
inflammation. The goal of our proposed studies is to determine how P. gingivalis SLs contribute to OMV cargo
loading and subsequently how these SL-OMVs modulate the host innate inflammatory response. We will
interrogate host sensing of P. gingivalis SL-OMVs both in vitro and in vivo. As early innate immune responses
control host responses at mucosal surfaces such as the oral cavity, we will employ unique genetically modified
P. gingivalis strains, and OMVs isolated from these strains to determine which OMV-components are involved
in suppression. Molecular, immunologic, imaging, and transcriptomic, and biochemical techniques will be
deployed to elucidate the underlying functions of SL-OMVs and mechanisms of host innate signaling. Lastly,
we will use oral bone loss modelling to examine the virulence of P. gingivalis strains that are altered in the
synthesis of SLs. The rationale for these studies is that identifying immunoregulatory mechanisms used by
oral pathogens will provide prime targets for the development of therapeutic strategies. Thus, the long-term
goal of this research program is to elucidate the mechanisms underlying SL-mediated OMV delivered immune
suppression and to determine if bacterial SL-synthesis can be targeted for treatment and prevention of
periodontal disease.

Public health relevance
NARRATIVE Chronic inflammation drives the destruction of the tissues supporting the teeth, and is the central driver of periodontal disease; however, this microbe-elicited immune response is insufficient to clear the host of periodontal pathogens such as Porphyromonas gingivalis. Our studies have recently identified the importance of sphingolipids synthesized by P. gingivalis as novel molecules capable of disrupting the host inflammatory response, and support that sphingolipid-mediated mechanisms may facilitate persistence of this organism in the host, thus providing a mechanism capable of modulation of the chronic inflammation that characterizes periodontal disease. The goal of this study is to understand precisely how P. gingivalis utilizes its sphingolipids to modulate host inflammation, with the vision toward development of novel periodontal disease treatment strategies that target these sphingolipids.